A Dual Role of Activin-like kinase 5 (ALK5)-mediated TGF Beta Signaling in Adult Neurogenesis

Project Summary
New neurons are added in the adult mammalian brain by a process known as adult neurogenesis and adult
neurogenesis is a key player in functional outcomes for learning and memory. One of the two known niches of
adult neurogenesis is the subgranular zone (SGZ) of the dentate gyrus (DG) in the hippocampus. It is known
that TGF-β signaling is crucial for neurogenesis during development while its role in adult neurogenesis remains
unclear. Due to the lethal phenotype in early neonatal mice of the global TGF-β knockout mice, the precise role
of TGF-β signaling in adult neurogenesis has been challenging to study. Chronic delivery of TGF-β in vivo inhibits
neurogenesis; however, inhibition of TGF-β signaling via knockout of the type I receptor (Alk5) in mature and
immature neurons also leads to compromised adult neurogenesis. Additionally, pharmacological modulation of
TGF-β signaling in previous studies affect multiple cells types including neurons and microglia which are known
to have an indirect role in regulating adult neurogenesis. Therefore, to understand the precise autonomous
requirement of TGF-β signaling in the process of adult neurogenesis during different stages such as proliferation,
differentiation, maturation, and migration, adult neural stem cell specific and inducible gene modulation models
are needed. To circumvent these challenges in the field, we have generated NSC- specific TGF-β receptor type
I (Alk5) or type II (TβRII) inducible knockout (iKO) mice which allows us to more specifically investigate how this
signaling pathway affects adult NSCs and downstream progeny. Preliminary data from our lab shows in vitro
pharmacological inhibition of TGF-β signaling with SB-431542 increases the proliferation of adult neural stem
cell (NSCs) while treatment with TGF-β inhibits the proliferation. This implicates TGF-β signaling in playing an
inhibitory role in the proliferation of adult NSCs. Additionally, our preliminary in vivo data from NestincreER-Alk5
iKO mice suggests TGF-β signaling is important for the maturation and migration of NSCs in the SGZ. We,
therefore, hypothesize a dual role of TGF-β signaling in the neurogenic cascade which inhibits the proliferation
of NSCs while simultaneously supporting maturation and migration in immature and mature neurons. The goal
of this current study is to determine the precise functions and mechanisms of TGF-β signaling in regulation of
adult neurogenesis through different stages and identify distinct target genes in each process. Although previous
studies provide evidence of TGF-β signaling influencing adult neurogenesis, there are conflicting results
throughout the field as TGF-β signaling is known to act in a highly context-dependent manner. With the specificity
of our in vivo mouse models, this proposal will provide novel insight on the cellular and mechanistic processes
involved with adult neurogenesis.

Public health relevance
Project Narrative Adult neurogenesis takes place in the SVZ of the lateral ventricles and the SGZ of the dentate gyrus in the hippocampus. While TGF-β signaling has been implicated in this process, the precise molecular mechanisms are not well known. This proposal will provide molecular insights for the regulatory role of TGF-β signaling in the addition of adult born neurons during different stages of adult neurogenesis.